Core 3: Outreach

Our U54 Outreach Core will facilitate the successful translation, implementation, and dissemination of research findings developed by U54 investigators. We build on the community relationships, strategies, and partnership developed during the P20 Planning period. Here we use “reverse translation” to bring community engagement to bench scientists. Traditionally, shared resource cores support research activities by providing cutting-edge tools, facilities, and well-skilled faculty to advance research. Yet there is often a gap in resources and knowledge of how research teams can ensure the translation of their findings from the basic science level (the “bench”) to the community and, also, from the community to the bench. Thus, the bi-directional potential of translational research has rarely been fully optimized. Building on the success of our P20, we aim for our UCR-CoHCCC U54 partnership to optimize the bi-directional potential of true community partnership. Our U54 Outreach Core moves beyond traditional community engagement to foster rigorous bi-directional, evidence-based strategies to narrow the divide. Aim 1 will facilitate the integration of community engagement across UCR-CoHCCC U54 research projects/pilots and cores. Aim 2 will provide technical assistance and training to community stakeholders so they can engage UCR-CoHCCC U54-sponsored research projects and cores. Aim 3 will facilitate the translation and dissemination of UCR-CoHCCC U54 findings to address knowledge gaps. The Outreach Core will democratize UCR-CoHCCC U54 data by using evidence-based and community-informed models of dissemination.